Geospatial and Ecological momentary assessment Technology and Activity Engagement for at-risk youth

Adolescence is associated with high risk for suicidal thoughts and behaviors (STBs). There is a need for interventions that target risk factors for STBs among a growing population of youth in the United States. Anhedonia, defined as the loss of interest or pleasure in enjoyable or valued activities, is a core feature of depression and an independent risk factor for STBs in youth. Behavioral Activation (BA) therapy is a cognitive behavioral intervention that directly targets anhedonia, by decreasing avoidance and isolation behaviors, using positive reinforcement to increase engagement in valued activities, and increase the experience of reward. Growing evidence supports the effectiveness of BA for adolescents in the traditional face-to-face psychotherapy format, and BA has shown promise in the few preliminary investigations that included youth. A key advantage of the BA model is that the focus on behavioral strategies is well suited for adaptation to digital platforms that incorporate mobile sensing and can generate objective data on activity. As the digital BA approach allows for real-time feedback to both users and providers on treatment goals and behavioral targets, it offers a significant advantage over traditional face-to-face intervention. To date, no studies have tested digital BA in a study population that includes youth representative of the pediatric primary care sample from which we recruit. The goal of this study, therefore, is to tailor and test a health coach supported, digital BA intervention to target anhedonia in a sample of youth from pediatric primary care. Our initial BA platform was developed by the investigators to collect mobile accelerometer and geospatial activity data using smartphone technology that is shared with a health coach or clinician to provide feedback and push BA intervention content via a smartphone app. We will use implementation science frameworks to tailor our BA intervention and implementation strategies for the target population. The Consolidated Framework for Implementation Research (CFIR) will allow us to collect and analyze qualitative data from focus groups with adolescents, caregivers, providers, and administrators on their perspectives of intervention needs, and barriers and facilitators to BA. Next, using human-centered design methods, we will iteratively develop and adapt the BA intervention to the needs of at-risk adolescents and their caregivers. We will then conduct a pilot randomized trial comparing the health coach supported digitally BA intervention to passive, smartphone-based activity monitoring alone. A group of 75 adolescents (ages 12-18) with moderate depression and elevated anhedonia symptoms, half of whom will also be suicidal, will be recruited from the Signature R01. We will examine feasibility, acceptability, and impact on anhedonia (primary target); secondary outcomes include activity, depression, and STB risk. This project will inform a larger randomized trial of BA and has the potential to directly address a critical gap in youth mental health research.